Multi-Functional Assessment of Vascular Networks

The overall goal of this study is to develop novel, non-invasive, functional vascular biomarkers to advance diagnostic capabilities and therapeutic strategies in a wide range of vascular diseases. Current imaging approaches to diagnose and monitor vascular disease such as computed tomography or magnetic resonance imaging are incomplete as they rely heavily on static characterizations of vascular anatomy. These approaches are insensitive to the dynamic vascular environment in which blood vessels pulsate, dilate, and constrict in real-time as they deliver blood into tissue. There is an urgent need for reliable, non-invasive biomarkers of vascular health. By using a multi-functional assessment approach focused on incorporating near-infrared spectroscopy (NIRS), vasoreactivity, and other imaging or sensor techniques, this research aims to develop non-invasive biomarkers of vascular function that can be deployed in the clinic for management of rare and common vascular diseases. Additionally, the study will explore the role of vascular development in influencing blood flow and/or tissue oxygenation levels. By including a diverse patient population with different vascular conditions, the study seeks to integrate functional assessments with clinical data to enhance our understanding of vascular disease mechanisms and development.